Cyclic Flow Cytometry for Ultra-High Marker Single-Cell Analysis

Abstract
Quantifying the presence, function, and fate of different immune cells is crucial in immunology
research and development of immunotherapies. Flow cytometry is a single-cell technique that is
widely used to measure different protein markers expressed by immune cells at high throughput.
However, spectral overlap between fluorophore labels makes measurement of more than 20
markers difficult, often requiring months of optimization, and limits the maximum number of
markers measured to around 40. These limitations prevent more comprehensive characterization
of immune cells that is critically needed for immunology and immune-oncology research. Mass
cytometry and RNA-seq based methods are throughput-limited and cost-prohibitive for measuring
patient blood samples containing millions of cells. The goal of this SBIR application is to develop
cyclic flow cytometry, a high-throughput, affordable and easy-to-use solution for the high-marker
single-cell analysis market. Cyclic flow cytometry leverages proprietary laser particle technology
to barcode individual cells for repeated flow measurements, enabling complex flow cytometry
experiments with 30 or more markers to be broken down into multiple, much easier cycles with
around 10 markers at a time. The feasibility of this innovative approach has been verified in the
Phase I research. The specific aims of this Phase II research involve developing and testing a
complete workflow and fully functional prototype for cyclic flow cytometry. The system will be
validated with external investigators for several applications. Completion of the Phase II work will
lead to early market validation of cyclic flow cytometry and directly lead to design of product-ready
prototypes, followed by commercial launch.

Public health relevance
Project Narrative Comprehensive immune cell profiling using flow cytometry is critical for understanding immune responses and developing immunotherapies. However, current flow cytometry is difficult to use when measuring more than a dozen markers, which limits the number of cell types and different cellular responses that can be characterized. Using novel laser particle technology, this project will develop novel cyclic flow cytometry to enable researchers to measure more markers in an easy-to-use manner, accelerating immunologic research and therapeutic discovery.